CatSper regulation of sperm physiology and fertility

PROJECT SUMMARY
Calcium signaling and homeostasis in spermatozoa is essential for successful fertilization. The overall goal of
this research program is to elucidate how sperm CatSper channel assembles to form Ca2+ signaling
nanodomains and integrates proteolytic and metabolic pathways to control mammalian sperm motility and fertility.
The research program aims to understand how calcium signaling and homeostasis in sperm is crucial for suc-
cessful fertilization, specifically focusing on the CatSper channel and its crosstalk with other signaling pathways.
During the first funding cycle, significant progress has been made in comprehending CatSper's role in sperm
motility and fertility. Molecular and structural organization, along with new CatSper components, were identified
through proteomic screens. In-depth studies using mouse models shed light on the channel's activity, assembly,
and trafficking. Additionally, 3D in situ molecular imaging revealed CATSPER1 as a molecular signature of suc-
cessful sperm reaching the fertilization site. Cryo-electron tomography further allowed the resolution of the first
in-cell CatSper structure in human and mouse sperm flagella, contributing to a clearer understanding of the
channel's composition and spatial arrangement.
This R01 renewal builds on new CatSper components identified, new animal models generated with novel strat-
egies, and new cutting-edge imaging techniques acquired during this period. Our studies reveal many unex-
pected features and broader implications of CatSper regulation of mammalian sperm physiology and fertilization,
laying the groundwork. We pursue the same long-term goals of deepening our understanding of sperm physiol-
ogy and uncovering new pathways that could be exploited to assess and control sperm motility and fertility with
new Specific Aims investigating 1] the role of ancillary transmembrane subunits in regulating channel assembly
and nanodomain organization; 2] the proteolytic regulation of the channel, and 3] its physiological significance
on the sperm energy metabolism, sperm motility and fertility.
Collectively, these new aims, leveraging work from the first R01, will elucidate the entirely novel molecular
mechanisms by which CatSper maintain and terminate sperm motility. This new knowledge will inspire im-
provements sperm selection in assisted reproduction and provide new targets for contraceptive development.

Public health relevance
PROJECT NARRATIVE The primary causes of male infertility are defects in sperm motility and capacitation, which require properly functioning Ca2+ signaling. The proposed research is relevant to public health because it aims to provide molecular insights into the sperm Ca2+ channel CatSper and the CatSper-organized signaling nanodomains, whose integrity is required for sperm energy metabolism, thus sperm motility and male fertility. The proposed research is relevant to the NIH’s mission because it will improve our understanding of sperm physiology and male fertility, which may enable the development of more effective strategies for the diagnosis, treatment, and prevention of conditions that affect male fertility, with the ultimate goal of promoting a better quality of life for all individuals.